Administrative Core A

Project Summary/Abstract (Core A, Portnoy)
The purpose of Core A is to ensure scientific progress and promote synergy by providing effective scientific
and administrative leadership and financial oversight to the program. These objectives will be accomplished
by extensive review of scientific progress at monthly meetings attended by all projects and cores within the
program and affiliated lab groups from around the Bay Area; smaller meetings held by subgroups; and
shared interviews of potential postdoctoral fellows. Scientific direction and research results will be subject to
intensive, constructive criticism by investigators within the P01 and by regular evaluations from an external
scientific advisory board. We strongly believe that our extensive collaborative approach promoted by Core A
is unique. Indeed, this program represents the nucleating group for Bay Area investigators studying
intracellular pathogens and innate immunity. The Specific Aims are: 1) Conduct management of scientific
progress; 2) Establish and engage external advisory board to review scientific progress; and 3) Implement
financial management and administrative support. To facilitate interactions among investigators, two-hour
joint lab meetings will continue to be held monthly at UC Berkeley. These monthly meetings consist of
introductory discussions and two scientific presentations from two different labs. Given possible restrictions
related to the coronavirus, we will use teleconferencing options for meetings, if necessary.
The external scientific advisory board, chaired by Dr. Jeffrey F. Miller from UCLA, will provide rigorous and
consistent evaluation of the program’s scientific direction, research results, and progress. Core A will
facilitate the relationship between the external board and the investigators as well as among the Project
Leaders themselves, who will meet once per month for 2 hours in the Program Director’s office. The Portnoy,
Vance, Cox, and Stanley labs each have a weekly lab meeting to review ongoing research in their respective
labs. In addition to the monthly meetings of P01 personnel and other Bay Area labs, there are many other
opportunities for investigators and trainees to interact, exchange ideas, and speak, including a weekly
Division of Immunology & Pathogenesis “Research in Progress” meeting on Mondays at noon with 2
speakers from 2 different labs; a seminar series from the Infectious Diseases & Vaccinology Group on
Mondays at 10 am, most speakers being from local labs; and the Microbial Biology Seminar Series, held on
Wednesdays at noon, with speakers from the US and across the world. Finally, we have an annual
immunology retreat at Asilomar that is held jointly with UCSF. Core A serves as the administrative nucleus
for the P01 and has been a critical element to our success.

Public health relevance
Project Narrative (Core A, Portnoy) The proposed studies will lead to the characterization of host systems of innate immunity that will lead to vaccines and/or therapeutics to prevent and/or treat infectious diseases, with relevance to domestic and global health. Core A will provide administrative support and promote synergy among all projects and cores.